Transcriptome-wide mapping of brain m6A methylome in Alzheimer’s disease

Alzheimer’s disease (AD) affects over 55 million people worldwide, and this number is expected to nearly triple
by 2050. AD is characterized clinically by progressive cognitive decline, and pathologically by amyloid plaques,
neurofibrillary tangles, and loss of neurons in the brain. A thorough understanding of its mechanism is a
prerequisite for discovering effective therapeutic interventions. N6-methyladenosine (m6A) is the most
prevalent post-transcriptional RNA modification that plays important roles in gene regulation and many other
biological processes including neurodevelopment, learning and memory. m6A is particularly abundant in the
brain and its dysregulation has been associated with neurological disorders. Yet, we still do not have a
complete map of m6A in the brain of older individuals and the mechanism by which m6A dysregulation may
causally contribute to AD also remains an enigma. We have recently developed several novel technologies for
transcriptome-wide quantitative m6A profiling at base-resolution. We have also validated the methods in a pilot
study consisting of 60 postmortem prefrontal cortex and identified multiple m6A alterations associated with
cognitive phenotypes and AD neuropathology (e.g., amyloid-β, tau tangles). Using these novel technologies,
the current study will test the hypothesis that brain m6A dysregulation is causally implicated in AD pathology.
Our objectives here are to 1) create the first high-resolution reference map of brain m6A methylome (i.e., all
m6A sites in brain) in the brain of older adults; 2) identify specific m6A alterations associated with AD and its
clinical and pathological endophenotypes; and 3) elucidate the mechanism by which m6A dysregulation may
causally contribute to AD pathogenesis. To achieve these goals, we leverage a large collection of human
postmortem brain tissue samples (dorsolateral prefrontal cortex) in two community-based cohorts of aging and
dementia: Religious Orders Study (ROS) and Rush Memory and Aging Project (MAP). Deep clinicopathological
phenotypes and rich brain omics data sets (e.g., GWAS, epigenomics, transcriptomics, proteomics) are
available in both cohorts. In Aim 1, we will perform quantitative profiling of brain m6A methylome and identify
specific m6A alterations associated with AD neuropathology. Aim 2 will integrate m6A data with other brain
omics data, including genomics (GWAS), epigenomics (DNA methylation, histone acetylation, and miRNA),
transcriptomics (RNA-seq) and proteomics, in the same brain cortex of same individuals, to decipher the
mechanism by which altered m6A methylation may trigger AD pathology. In Aim 3, we will use a dCas13b-FTO
fusion for m6A editing in human induced pluripotent stem cells (iPSC)-derived neurons to functionally validate
the top-ranked genes and determine the causal role of m6A dysregulation in AD pathogenesis. Such results will
provide novel mechanistic insight into the role of m6A dysregulation in AD pathology and inform the
development of therapeutic interventions targeting m6A and its regulatory pathways for AD treatment.

Public health relevance
Alzheimer’s disease (AD) is the most common cause of dementia affecting over 55 million people worldwide, and this number is expected to triple by 2050. This project examines the potential causal role of a new molecular mechanism, called N6-methyladenosine (m6A), in AD pathogenesis. Findings of this study will provide new insight into and are likely to lead to novel therapeutic tools for AD treatment.